Integrating investigational miR371a-3p with conventional radiology imaging for earlier and more precise detection of active germ cell malignancy: A BCC/SWOG/S1823 secondary use of data collaboration.

Project Summary
Background. While miRNAs have not demonstrated to be easy therapeutic targets, growing evidence
suggests that they are reliable diagnostic biomarkers in germ cell tumors (GCTs). GCTs are embryonally and
biologically very distinct from other solid malignancies and retain most of the embryonal stem cells
characteristics, including expression of a specific subset of miRNAs. miR371a-3p (miR371) has high accuracy
to identify active germ cell malignancy (aGCM) in both seminoma and nonseminoma GCTs. In order to move
this biomarker forward into the clinical practice, 2 clinical trials have been designed and are currently accruing
patients in the pediatric (AGCT-1531) and adult GCT populations (S1823). S1823 is a SWOG-lead cohort trial
that has the objective to prospectively and clinically validate miR371 in adult GCT.
Taking advantage of our group leader position in S1823, we are proposing to utilize the plasma miR371
expression data and the radiologic images coupled with clinical data collected for S1823 to create a biological-
clinical predictive model of aGCM in patients with early stage GCT on surveillance.
Hypothesis. miR371 has higher PPV than standard of care clinical tools to identify aGCM in early stage germ
cell tumors and it can be used to identify tumor relapse earlier and with more accuracy.
Aims. The aims of this research project are to:
1. Measure plasma miR371 expression in S1823 specimens at baseline and during the follow-up.
2. Integrate/compare the qualitative and quantitative miR371 expression with the clinical annotation as detailed
in the S1823 trial design.
Methods. The baseline and the serial samples collected during the surveillance from the patients enrolled in
S1823 will be analyzed for miR371 expression using RT-PCR. The CT scan images data collected at the same
time point of miR371 will be compared to miR371 expression for the determination of the PPV, NPV, sensitivity
and specificity. The accuracy of the tests individually or combined will be analyzed to define the AUC of the
ROC and to create a predictive model of aGCM that integrates clinical and biological data.
Innovation. The innovation of this research proposal resides neither in the quite basic and universal RT-PCR
technique used for the miR371 expression, nor in the simple statistic and study design. The innovation consists
in the potential clinical utilization of this highly specific biological marker for early detection of aGCM which will
open more opportunities for replacement or integration of conventional images, treatment de-escalation and
personalization on the base of biological rather than clinical evidence of GCTs.
Significance and impact: Early and more accurate identification of aGCM during surveillance has the
potential to reduce treatment burden of the young GCT patients’ population and to prevent long term side
effects of chemo and radiation treatments with meaningful improvement of GCT patients’ quality of life.

Public health relevance
Project Narrative A new blood test (miR371) appears to be highly accurate in predicting active germ cell tumors. Current clinical tests such as CT scans and standard tumor markers appear less accurate than miR371 and can lead to misdiagnosis of active germ cell malignancy, overtreatment and unnecessary treatments and significant expense and toxicity. We are proposing a clinical investigation to evaluate the ability of miR371 testing compared to or integrated with CT scan images to reduce, replace or potentiate the use of the current clinical tools and reduce the exposure of patients to unnecessary and somewhat toxic interventions.